Proteomics and Metabolomics Shared Resource

PROTEOMICS AND METABOLOMICS SHARED RESOURCE (PMSR): PROJECT SUMMARY
The Proteomics and Metabolomics Shared Resource (PMSR) provides advanced mass spectrometry services,
technologies, data analysis, and scientific consultation for global and targeted proteomics, metabolomics, and
lipidomics to support Wake Forest Baptist Comprehensive Cancer Center (WFBCCC) efforts in precision
oncology—one of the Cancer Center’s top strategic priorities. More broadly, PMSR specializes in discovery,
identification, characterization, and quantification of biomolecules, drugs, and biologically active natural
compounds by mass spectrometry and biochemical methods, and chromatography of proteins, peptides, lipids,
and nucleic acids. Technology assets of PMSR include a Thermo Q-Exactive HF with Vanquish UHPLC for
metabolomics and lipidomics services, a Shimadzu LCMS-8050 Triple Quadrupole, and a SCIEX Triple Quad™
6500+ LC-MS/MS System for targeted analysis of small molecules (drugs, metabolites, natural products), a
Thermo Orbitrap Velos Pro w/ETD MS with UltiMate™ 3000 RSLCnano system for proteomics, and a series of
HPLC systems with UV-VIS and fluorescence detection. PMSR also has access to MS instruments in the Center
for Precision Medicine (e.g., Thermo Orbitrap Fusion Lumos Tribrid and Thermo GC Q-Exactive HF mass
spectrometers) and instruments in the PMSR Co-Director’s personal laboratory (Agilent 6120 MSD ESI-TOF
MS). The institution has scheduled the acquisition of a Thermo Scientific Orbitrap Eclipse w/ETD for the PMSR
in the first quarter of FY22 (07/2021). Expertise and technical support for metabolic flux studies are provided in
partnership with the University of Kentucky Resource Center for Stable Isotope-Resolved Metabolomics (one of
the resource centers funded by the NIH Common Fund and associated with the NCI-Designated Markey Cancer
Center). PMSR is directed by Cristina Furdui, PhD, and Mark Lively, PhD, and is supported by five highly
trained staff. Over the recent years, the Wake Forest School of Medicine and WFBCCC provided critical support
to maintain high-quality operations in the PMSR, contributing $108,965 to match the $200,000 awarded by North
Carolina Biotechnology Center for the purchase of the Shimadzu LCMS-8050 mass spectrometer in 2017,
$46,708 to purchase a new Vanquish UHPLC system in 2018, and $6,230 to purchase the Sigma Mass
Spectrometry Metabolite Library. PMSR is managed by WFBCCC and is supported financially by the CCSG, the
Wake Forest School of Medicine, and a chargeback mechanism. During the reporting period, the PMSR
supported the research of 31 WFBCCC users (up from 17 reported at the previous CCSG renewal); 41 cancer
grants; 5 clinical studies; and 30 publications. Total usage since 2016 corresponded to 33,291 hours (19,627
fee-for-service, 9,109 for development of new methods, and 4,555 for quality control and optimization).